Effects of Manually Recorded or Automatically Transmitted Home Blood Pressures with or without Automated Patient Feedback on Hypertension Care

PROJECT SUMMARY/ABSTRACT
Despite a strong evidence base demonstrating that controlling hypertension greatly reduces cardiovascular
health risk, hypertension control remains poor, and has worsened in the past decade. Accurate and regular
blood pressure measurement is essential to safely achieving blood pressure targets. Office blood pressure
measurements have many known limitations, so achieving proper diagnosis, optimal control, and avoiding
overtreatment requires repeated out-of-office measurement. Care strategies incorporating home blood
pressure monitoring and proactive team-based care have been some of the most effective ways to improve
hypertension control but face numerous barriers to implementation in routine practice and are not widely used.
Lighter-touch, digitally-enabled strategies are practical and can be delivered via patients’ existing electronic
health records and tied to their usual source of care. If effective, these strategies may ultimately prove easier to
implement in practice than more labor intensive strategies. The first aim is to conduct, in patients with
uncontrolled hypertension at a large diverse health system, a 2x2 factorial patient-randomized controlled trial
(the AUTO2 Trial) to evaluate the effects of 1) AUTOmated transmission of remotely-obtained blood pressure
values versus manual transmission, and 2) AUTOmatically-generated medical advice to patients related to
their home blood pressure monitoring results sent via patient portal messages versus no automated feedback.
The primary outcome will be systolic blood pressure at 1-year. Persistence of effects through 18 months will
also be assessed. The second aim will assess whether these two interventions interact. Automated messaging
that includes prompting to perform self-monitoring and other feedback could lead patients to sufficiently self-
report their blood pressures and obviate the need for direct transmission of blood pressures. Alternatively, the
two interventions could have synergistic effects leading to more than additive benefits. Third, we aim to
evaluate intervention effects on resource utilization and clinician attitudes towards the use of these remote
monitoring systems and examine how the remote blood pressure monitoring information is used by physicians,
advanced practice providers, and their teams to deliver patient care. This trial has the potential to demonstrate
the effectiveness of practical strategies to accelerate the achievement of evidence-based hypertension
treatment goals that could be incorporated into existing health systems. Public health benefit: A modest
reduction in population systolic blood pressure of 5 mm Hg or even less is expected to produce important
reductions in cardiovascular events, stroke and heart failure and to confer other important health benefits.
Identifying and testing light-touch strategies to accelerate the achievement of evidence-based hypertension
goals that are feasible and affordable for health systems to implement and for patients to use is needed to
realize the proven benefits of controlling hypertension.

Public health relevance
PROJECT NARRATIVE Hypertension is a leading cause of death and disease but is often uncontrolled due to factors such as clinician and patient inertia, uncertainty about someone’s true blood pressure level, and lack of proactive follow up leading to inadequate medical treatment. This trial will test whether medical advice generated by computer and sent to patients through their electronic medical record improves blood pressure. It will also test whether it is helpful to automate the reporting of home blood pressures to healthcare teams rather than relying on patients to enter this information manually.